A Pragmatic Randomized Control Trial of Nurse-Delivered Brief Meaning Centered Psychotherapy for Homebound Palliative Care Patients

Project Summary/Abstract: Patients with serious illness are often confronted with existential distress that
contributes to anxiety and depression and when left unaddressed, leads to increased suffering and despair.
Homebound individuals face compounded existential concerns and loss of meaning above and beyond
ambulatory patients with advanced illnesses, as they contend with an even greater loss of independence and
declining opportunities for activities and social engagement. Nonetheless, this group has been described as
“invisible” due to a lack of consensus on quality of care benchmarks. Despite this great need, most of these
individuals do not receive mental health services. As the demand for the delivery of comprehensive, high
quality palliative care in the community continues to grow, so too does the need to address these vulnerable
patients’ existential and emotional needs with targeted interventions that can be feasibly delivered in the home.
This study seeks to evaluate the impact of a brief nurse-delivered psychosocial intervention, Meaning Centered
Psychotherapy – Palliative Care (MCP-PC), to homebound adults with advanced cancer. This pragmatic trial is
conceptualized through the lens of dissemination and implementation (D&I) science using the Iowa Model of
Evidence Based Practice indicators (i.e., knowledge, perception/attitude, behavior/practice, outcomes,
balancing measures). Using a mixed methods design, including a pilot randomized control trial, this study has
three specific aims: (1) To refine the MCP-PC training and study procedures for homecare delivery by nurse
interventionists through a single arm open pilot (n=10 nurses; n=10 patients); (2) To evaluate the feasibility and
acceptability (Iowa Model knowledge, perception/attitude, behavior/practice, balancing measures) of nurse-
delivered MCP-PC in an RCT (n=10 nurses; n=60 patients); and (3) To assess the efficacy of nurse-delivered
MCP-PC compared to treatment as usual (TAU) on patients’ spiritual well-being, psychological distress, QOL,
and end of life despair (Iowa Model outcomes) in an RCT. After a brief open pilot and refinement of study
procedures, we will recruit 60 patients through the Visiting Nurse Service of New York (VNSNY) home-based
care program and randomize them to either MCP-PC or TAU. All participants will be asked to complete a short
battery of self-report instruments at baseline, after treatment, and one-month post-treatment (TAU
assessments will follow a similarly spaced time line). Brief qualitative interviews evaluating the treatment and
implementation outcomes will be conducted with patients and nurses upon completion of MCP-PC. The MCP-
PC program leverages the existing infrastructure of a high-volume homecare agency to address the insufficient
mental health workforce in palliative care. If proven effective, MCP-PC can be successfully embedded in
existing systems of care as a potentially widely disseminable approach to reaching historically underserved
patient populations (e.g., rural, ethnic minorities) on a national scale.

Public health relevance
PROJECT NARRATIVE There is an urgent need to develop implementation strategies for delivering psychological interventions to homebound patients with serious and advanced illnesses while ensuring quality of care. The current proposal leverages implementation science to further the NINR’s mission to develop, test, and disseminate novel, scalable symptom management interventions by evaluating nurse-delivered MeaningCentered Psychotherapy - Palliative Care (MCP-PC) to homebound patients with advanced cancer. If proven effective, MCP-PC can be rapidly integrated into existing systems of care as a widely disseminable approach to ameliorating distress among historically underserved patients in the community.